Trajectories of ovarian reserve and cardiovascular risk in Black and White women

Abstract
The reproductive lifecycle of a women can affect her long-term health including onset of
cardiovascular disease. The menopausal transition affects the onset and timing of
cardiovascular changes that can lead to long term health consequences. There is a link
between the age at menopause and cardiovascular mortality and heart failure, as earlier onset
of menopause is associated with higher rates of cardiovascular disease. The size of the ovarian
follicle pool and cessation of ovarian hormone production is a key factor that influences the
timing of menopause. Serum anti-mullerian hormone (AMH) has emerged as an important
marker of the ovarian follicle pool. AMH has been shown to reflect the gradual decline in
reproductive capacity with increasing age. Early decline in AMH and a more rapid trajectory of
decline have been associated with increased risk for cardiovascular disease. This study
supplement will test AMH values at multiple timepoints over the reproductive lifespan by utilizing
stored samples and prospective samples from the NHLBI Growth and Health Study (NGHS).
NGHS enrolled 871 girls (50% Black and 50% White) in 1987 at age 9 or 10 and examined
them up to 17 times, to age 27, including 7 echocardiograms between ages 20-27, multiple
saved samples and reproductive history questionnaires. The parent study for this supplement
will be enrolling 350 NGHS participants in the late reproductive stage (average age 46) and
collecting cardiovascular labs and imaging as well as update lifetime information on
socioeconomic status and social determinants of health. This supplement will add assessment
of ovarian reserve trajectory of time to: 1) Determine differences in the ovarian reserve and its
trajectories between Black and White women and how the social determinants of health (SDOH)
impact this difference; 2) Determine if the trajectory of ovarian reserve decline across the
reproductive life-course affects cardiovascular disease risk or disease. In addition, this
supplement aims to create a study participant advisory group to help optimize study recruitment
and retention particularly in Black women. With completion of our aims, we will understand the
effect of SDOH and race on ovarian reserve as well as determine if the rate of ovarian reserve
decline can be a marker for future cardiovascular disease. This supplement is designed to
enhance the parent grant by adding additional information about the reproductive system
affecting cardiovascular disease as well as provide mechanisms to improve subject recruitment,
retention, and satisfaction with the study.

Public health relevance
Project Narrative The menopausal transition plays an important role in the timing and onset of cardiovascular disease regardless of age. The decline in ovarian reserve is a key determinant of menopause timing; however, it is unclear whether the rate at which the ovarian reserve declines through a women’s reproductive years affects timing and onset of cardiovascular changes. This study will leverage a unique longitudinal cohort of Black and White women throughout the reproductive years to determine ovarian reserve trajectory and how it relates to cardiovascular disease risk.